DP24-004, PRC, Core: Prevention Research Center at UMass Chan

Our overarching goal of the Prevention Research Center (PRC) at UMass Chan Medical School is to establish,
disseminate and translate dissemination and implementation (D&I) prevention research evidence that builds the
capacity of local health departments (LHDs) and community agencies to equitably implement evidence-based
prevention interventions (EBIs) using community-engaged approaches. Located in Worcester, MA, the proposed
work builds from: (1) a well-established, institutionally supported Center infrastructure, (2) a committed, multi-
sector Community Advisory Board (CAB), (3) established relationships with statewide and national translation
partners, and (4) D&I prevention research expertise. Our application focuses on FOA priority category #9. The
EBI of focus is The Guide to Community Preventive Services (Community Guide) recommendation for built
environment changes to promote physical activity (Community Design EBIs). Community Design EBIs include
policies and plans that improve transportation and land use systems to promote physical activity. Aim 1 is to
maintain and expand a Center infrastructure that supports D&I prevention research, partnerships, capacity
building, communication, dissemination and translation activities. A multi-sector CAB and a national
Dissemination and Translation Advisory Board (D-TAB) will guide all activities. Aim 2 is to conduct a community-
engaged D&I Core Research Project to increase physical activity and reduce disparities in physical activity
participation through community-engaged implementation of Community Design EBIs. Guided by the Interactive
Systems Framework for public health implementation and informed by preliminary research, our project will test
the implementation of Neighborhood Connect, which prepares LHDs to support local community design decision-
makers and to work with partners to engage diverse neighborhood teams and build their capacity to: (1) Connect
as a Community by fostering buy-in on the importance of the built environment for physical activity and
accompanying co-benefits (e.g., traffic safety, economic development) and learning civic participation principles,
(2) Connect with the Environment by conducting neighborhood audits to document and understand
neighborhood built environment issues, and (3) Connect with the Policy Process by identifying and engaging
with decision-making processes in their jurisdiction to promote built environment improvements. We will evaluate
the Neighborhood Connect implementation strategy in a mixed methods neighborhood-level stepped-wedge
design study in 8 Worcester, MA neighborhoods with the lowest rates of physical activity and whose populations
are low-income, racially and ethnically diverse and experience health disparities. Neighborhood resident,
implementation partner and policy/plan level outcomes will be assessed. Aim 3 is to position the PRC at UMass
Chan as a valued, productive PRC Network member, deeply involved as a leader and collaborator in PRC
Network research, dissemination and translation activities. We also propose to lead a new Community Design
D&I Work Group to network and foster shared learning, methods and dissemination and translation activities.

Public health relevance
The proposed Prevention Research Center at UMass Chan Medical School includes: (1) A Center infrastructure to support development, dissemination and translation of strategies that build the capacity of local health departments, community agencies and community members to implement evidence-based prevention interventions; (2) A Core Research Project that will test a Neighborhood Connect, a strategy designed to prepare local health departments to work with cross-department collaborators, community partners and community members to implement policies and plans for community design that promote physical activity and reduce disparities; and 3) Contributions to the national PRC network through leadership and participation in network activities and collaborations.